A universal, scale-independent artificial intelligence-based platform for manufacturing high titer bacteriophage preparations for clinical applications

A universal, scale-independent artificial intelligence-based platform for manufacturing high titer bacteriophage preparations for clinical applications.